Role of TNFalpha in discogenic pain progression and as a treatment target

Summary
Back pain is a leading cause of global disability and intervertebral disc (IVD) disorders play a role in specific and
non-specific pain and disability. While spinal surgery can effectively address specific causes of pain, discogenic
pain, or axial back pain with IVD degeneration as the most common diagnosis, is non-specific and lacks effective
treatment strategies. Causes of discogenic pain are hard to identify since radiographic IVD degeneration is
common in both symptomatic patients and pain-free controls, and treatment strategies are also non-specific.
Hence, a critical need exists for targeted and novel interventions for discogenic pain, yet current science is limited
by a lack of fundamental information on how IVD injury progresses to neuroinflammatory pathologies, and how
this can be modulated. In fact, surprisingly little is known about how IVDs and dorsal root ganglia (DRGs) interact
in response to IVD injury and degeneration, although chronic inflammation involving tumor necrosis factor alpha
(TNFα) plays a key role. Furthermore, almost no studies on sex differences in discogenic pain exist despite
known sex differences in pain transmission. This project addresses how IVD injury progresses to chronic
discogenic pain involving IVD degeneration and DRG neuroinflammation, and how this can be modulated. Our
premise is that IVD injuries progress to chronic discogenic pain via TNFα-modulated IVD degeneration, and
DRG sensitization and remodeling; and that the treatment of long-term discogenic pain is refractory with simple
treatments and requires interventions that target both IVD and neural pathologies. We developed a robustly
characterized in vivo rat discogenic pain model and novel interdisciplinary collaborations. Pilot results
demonstrate that TNFα is an essential factor in the onset of IVD degeneration and pain, and that TNFα receptor
1 (TNFR1) and TNFR2 have distinct roles in the inflammatory cross-talk between IVDs and DRGs needing further
investigation to understand pathophysiology and identify treatments. Aim 1 determines the role of TNFα and its
receptors in the progression from IVD injury to chronic discogenic pain using a rat discogenic pain model and
human IVD cells. Aim 2 uses single cell RNAseq (scRNAseq) to identify IVD and DRG cells and molecular
pathways important in long-term discogenic pain that are TNFα-mediated and affected by Atsttrin, a novel drug
that blocks TNFR1-related catabolism and promotes TNFR2-related anabolism. Aim 3 treats chronic discogenic
pain using Atsttrin, Duloxetine (an anti-depressant with efficacy for neuropathic pain), and combined treatments
to address both IVD degeneration and neuropathology. Aims use rat in vivo models and human in vitro cell
culture model systems with behavioral, gene and protein measurements, as well as next generation sequencing.
Outcomes of this project include determining the role of TNFα and its receptors in onset and progression of
discogenic pain; identifying TNFα-modulated cells and molecular pathways critical in the IVD-DRG of cross-talk
in long-term discogenic pain; developing novel treatment strategies for chronic discogenic pain; and identifying
potential sex differences in discogenic pain pathophysiology and treatment.

Public health relevance
Narrative Discogenic pain is a major contributor to back pain and a leading cause of global disability with few effective treatments. This project determines inflammatory factors, specifically the role of tumor necrosis factor alpha (TNFα) in the onset and progression of discogenic pain including identifying neuroinflammatory interactions and cross-talk between intervertebral discs and dorsal root ganglia in rat and human model systems. We also apply cell and animal models and use next generation sequencing analyses to identify mechanisms and screen novel targets for efficacy in treating chronic discogenic pain.